Animal Food Regulatory Program Standards Implementation Maintenance, with Mutual Reliance Initiatives

Project Summary/Abstract for PAR-25-003 Animal Food Regulatory Program Standards
Implementation Maintenance, with Mutual Reliance Initiatives.
The Nebraska Department of Agriculture (NDA) and its Commercial Feed Program are
excited for the opportunity to continue its effort of maintaining the Animal Feed Regulatory
Program Standards in the State of Nebraska. The State Program’s goals in maintaining full
implementation of AFRPS is to continue to maintain its animal food safety contract in good
standing with FDA throughout the period of the contract agreement; continue meeting all
reporting obligations of the cooperative agreement along with usage of the Improvement
Plan from Standard 9 to track and implement changes and improvements; and maintain
risk-based firm inventory and enhance the criteria for determining risk. The State Program
has begun Phase 2 of the SMG-8076 audit program and plans to conduct 3 audits for this
fiscal year. In the Mutual Reliance Track, the program plans to conduct 5 to 9 non-contract
comprehensive inspections in year 1 following FDA’s risk ranking and cover-by dates.
Additionally, the program will utilize risk-based workplanning, work sharing and data
exchange in an effort to eliminate the duplication of work, along with synchronization of firm
inventories. The State Program will consider the possibility of increasing non-contract
inspections for mutual reliance in years 2 and 3 based upon lessons learned in year 1.

Public health relevance
Project Narrative for PAR-25-003: Animal Food Regulatory Program Standards Implementation Maintenance, with Mutual Reliance Initiatives. The Nebraska Department of Agriculture (NDA) will continue to maintain Full Implementation status of the Animal Food Regulatory Program Standards and looks forward to implementing Mutual Reliance Initiatives. Risk-based workplanning, work sharing, data exchange, developing and standardizing processes, procedures, and systems to integrate federal and state animal food regulatory work, will help advance the mutual reliance effort. Continuous improvement of the partnership between the state program and FDA will help to create a fully integrated food safety system and ensure the health and safety of livestock, pets, and humans by confirming that animal food is safe and unadulterated.